Clinical Translational Research Center for Neurodevelopmental Disorders

Project Summary
The University of North Carolina Intellectual and Developmental Disabilities Research Center (IDDRC) is an
interdisciplinary program with the overarching goal of supporting and promoting research relevant to
understanding the pathogenesis and treatment of neurodevelopmental disorders. The UNC IDDRC is a critical
component of the new Carolina Institute for Developmental Disabilities (CIDD), which is the focal point for
clinical services, research, and training relevant to intellectual and developmental disabilities (IDDs) on the
UNC campus. The UNC IDDRC currently supports 46 investigators from 13 University departments, and
includes 89 externally-funded research projects. The broad-based research program of this IDDRC is
integrated around 3 themes: (1) Brain and Behavior Development; (2) Autism and Related
Neurodevelopmental Disorders; and, (3) Early Detection/Intervention. The UNC IDDRC is a highly
collaborative program highlighted by the presence of several NIH-funded, interdisciplinary research
centers/programs. This application seeks support for: (1) an Administrative Core; (2) three research cores –
the Clinical Translational Core, which includes the Research Participant Registry and Brain-Behavior
Measurement Laboratory; the PreClinical Core, which includes the Mouse Behavioral Phenotyping Laboratory,
Neuroscience Microscopy Facility, and Small Animal Imaging Facility; the Data Science Core Core; and (3) a
pre-clinical/clinical research project entitled “Cerebrospinal fluid abnormalities in neurodevelopmental
disorders” that proposes to examine role of CSF pathophysiology in the pathogenesis of selected
neurodevelopmental disorders. The three proposed research cores provide cutting-edge, high-quality and cost
effective support for this integrated, multidisciplinary, translational program of IDD-relevant research. Overall,
this Center has had a major impact on developmental disabilities research and scientific training at the
University of North Carolina, and renewal would allow us to continue our support of the truly exceptional
program of IDD research conducted at UNC.

Public health relevance
Project Narrative The proposed Intellectual and Developmental Disabilities Research Center will support research cores that provide critical resources to 46 established investigators and one signature research project. The combined effort of both the cores and investigators is highly likely to have an important positive impact on research relevant to understanding the pathogenesis and treatment of intellectual and developmental disabilities.